Building Research Capacity in Global Tobacco Product Regulation Program

Project abstract:
The tobacco products consumed by the world's one billion smokers are highly engineered,
meticulously marketed and, for about 50% of users, lethal. More so than many other dangerous
products, regulating tobacco manufacture, labeling, sale, distribution, advertising and promotion
has proven particularly challenging in many contexts, even with strong legislation like the Family
Smoking Prevention and Tobacco Control Act (Tobacco Control Act), P.L. 111-31. Through this
project, WHO will use its unique history, position, networks and contacts in international tobacco
control and tobacco product regulation efforts to support the Food and Drug Administration (the
FDA) in its approaches to reducing tobacco use, harm and addiction. WHO's experience in this
area includes managing the Study Group in Tobacco Product Regulation (TobReg), the
Tobacco Laboratory Network (TobLabNet), its Collaborating Centres in Tobacco Product
Regulation, the Global Tobacco Regulators Forum (GTRF), and, for the past three years, the
WHO-FDA Cooperative Agreement “Building Research Capacity in Global Tobacco Product
Regulation Program”. Building on lessons learned and these extensive networks, this project
proposal sets out a number of science-based activities over the next five years. These include
development and coordination of multilateral research efforts in science, law, policy and public
health communications. Because sound data is the cornerstone of good regulation, activities will
also expand data collection and information sharing mechanisms, management and reporting
protocol. A separate reporting activity will ensure that WHO carefully monitors and evaluates
program activities, processes and outcomes. As the FDA's Center for Tobacco Products (CTP)
considers its mandate to place restrictions on the sale and distribution of tobacco products,
implement tobacco product standards, review applications for new tobacco products, and
consider applications for modified risk products, the information from this project will enable US
regulators to consider global trends, existing and new scientific literature, and relevant
evidence/information from other countries. Since CTP now has authority to regulate all tobacco
products, including novel products that may not be on the U.S. market yet, it is particularly
important to learn from other regulators and researchers with relevant experience.

Public health relevance
Project narrative WHO's Tobacco Free Initiative, through this project, will continue its work in strengthening and expanding the research foundation for tobacco product regulation, including comprehensive data collection, expert insight and analysis, and other scientific, legal and policy research. This will include contextual factors relevant to the US tobacco product regulation that will facilitate comparative analysis, in order to support the FDA's implementation of the Tobacco Control Act, with a view to reducing domestic tobacco-related death and disease. Further, information on global trends, scientific literature, research and policy will support regulatory efforts, as well as evaluation opportunities in other countries and the US, especially with respect to novel products that may not yet be on the US market but for which CTP has regulatory oversight.